BCR Signaling in ABC DLBCL

Objectives: Establish the safety and the maximum tolerated dose (MTD) of orallyadministered PCI-32765 in patients with recurrent B cell lymphoma. Determine pharmacokinetics (PK) of orally administered PCI-32765 Measure pharmacodynamic parameters to include drug occupancy of Btk, thetarget enzyme, and effect on biological markers of B cell functionSamples for pharmacokinetics and pharmacodynamics will be collected as outlined in theprotocol and shipped to Pharmacyclics, Inc. as specified below. Tissue samples will notbe sent to Pharmacyclics, Inc. Rather, tissue samples will be obtained as outlined below.Biopsy specimens will be required from all patients before initiation of PCI-32765treatment (pre-treatment biopsies). It is anticipated that roughly half of the patientswill have accessible tumor tissue and will be rebiopsied prior to PCI-32765. Thesepatients will also be biopsied 48 hours after the initial PCI-32765 dose. For the otherpatients, formalin fixed and paraffin embedded (FFPE) samples from previous biopsieswill be analyzed.Gene expression profiling using Affymetrix U133plus2.0 arrays will be performed for allcases. For those cases with available fresh frozen pre-treatment biopsy samples, geneexpression profiling will be performed as described by the Staudt laboratory, withassignment to ABC or GCB subgroups based on a Bayesian predictor (Wright et al.PNAS 2003, 100:9991). On these patients, we will also obtain biopsy samples 48 hourspost-treatment and profile gene expression similarly. Comparison with the pre-treatmentsample will allow us to assess the ability of PCI-32765 to inhibit btk. For patients withonly an FFPE biopsy sample, we will use a newly described method that can use RNAfrom FFPE biopsies to accurately predict ABC vs. GCB DLBCL subtypes (Williams etal. J Mol Diag 2010, in press). Briefly, RNA is extracted from FFPE samples with aQiagen FFPE extraction kit followed by amplification using a kit from Nugen, prior tostandard Affymetrix U133Plus2.0 array analysis. We will also perform where possibleanalyses of tumor mutations which include but are not be restricted to CARD11, ITAMand A20.